Improving COVID-19 Vaccine Uptake Among Racial and Ethnic Minority Groupswith Rheumatic Diseases

PROJECT SUMMARY
Black and Latinx individuals are at higher risk for certain autoimmune rheumatic diseases (AIRDs) and have
experienced worse COVID-19 outcomes compared to their white counterparts. The American College of
Rheumatology recommends beyond the initial COVID-19 vaccination, subsequent COVID-19 vaccine doses to
complete the primary vaccination series and a booster dose in people with AIRD. Yet, historically, overall
vaccine uptake among people with AIRDs has been low, and this vaccine reluctance has extended to COVID-
19 vaccination. This proposal will harness community-engaged methods to develop and test the effectiveness
of a multi-modal intervention that combines “storytelling” videos and patient navigation to increase uptake of
recommended COVID-19 vaccination among Black and Latinx AIRD patients in two distinct US geographic
regions. Aim 1 will develop a multi-modal intervention that includes a) “storytelling” videos we will produce with
vaccinated Black or Latinx patients with AIRDs narrating their COVID-19 vaccination experiences, and b) a
patient navigation approach to encourage recommended COVID-19 vaccination. Navigators will be trained
using virtual case simulation to discuss up-to-date guidance and provide logistical support for vaccination. In
Aim 2a we will recruit 1,170 racial and ethnic minority patients from 4 rheumatology clinics in the Southern and
Northeastern U.S. to participate in this patient-level, randomized, controlled, parallel group trial. Participants
will be randomized to receive at the routine clinic visit either “storytelling” OR an “attention-control” plus usual
care. At the clinic visit, coordinators will invite participants to view “storytelling” videos on tablet computers
deployed in a private clinic area. At 2 days after the clinic visit, the navigators will contact each participant
remotely (phone/video calls) to provide customized assistance for vaccination. A second contact will occur ~2
weeks later. We will examine the differences in rates of COVID-19 vaccine receipt between racial/ethnic
minority participants with AIRD exposed to our multi-modal intervention versus an “attention-control” video
(focused on the merits of a balanced diet/exercise on health status) plus usual care. We will measure rates of
receipt of subsequent COVID-19 vaccination at 3 months after the clinic visit using extant linkages to state
vaccination records (primary endpoint). We will measure via surveys COVID-19 vaccine confidence, influenza
vaccine uptake (self-report) as a proxy for intervention effect on vaccination behavior for other vaccines, self-
efficacy, and social health. We will explore whether insurance status and education moderate COVID-19
vaccine uptake. In Aim 2b, using surveys and semi-structured interviews, we will assess how intervention
components achieved their effects to inform future scale-up of our intervention. Beyond our innovative
approach and experienced team, a key strength of our study is its generalizability since we are including two
geographically distinct regions with substantial ethnic/racial diversity in their populations that deliver care to
many uninsured, Medicaid, and other historically marginalized groups.

Public health relevance
PROJECT NARRATIVE People with autoimmune rheumatic diseases (AIRDs) such as rheumatoid arthritis or systemic lupus erythematosus, especially those on immunosuppressive treatment, often experience poorer outcomes following COVID-19 infection. Individuals with AIRDs, including Black and Latinx persons, are concerned about side effects, may have limited awareness about the complexity of COVID-19 vaccination and timing of subsequent vaccine doses in the context of AIRD and/or immunosuppressive treatment, or may have barriers to obtaining a COVID-19 vaccine dose. This study aims to test whether a novel intervention using first-person narratives (i.e., “storytelling”) recounting personal experiences with the COVID-19 vaccination as well as patient navigation to provide logistics support for and reinforce safety and effectiveness of COVID-19 vaccination will result in an increase in vaccination uptake among Black and Latinx adults with AIRDs.